Johns Hopkins Institute for Clinical and Translational Research

The Institute for Clinical and Translational Research (ICTR) Hub is a collaboration between universities in the Baltimore, MD area, including Johns Hopkins University (Hub lead), University of Maryland Baltimore (UMB), and Morgan State University (MSU). The ICTR supports research collaborations between universities and community-based health systems to address health problems important to the community. The overall vision of the ICTR Hub is to improve the health of the State of Maryland, with an emphasis on rural and urban areas where access to medical care and clinical research is low. The ICTR Hub will coordinate state-of-the-art precision medicine, population health, omics, imaging, and informatics to expand and harmonize translational research from our partner institutions in Maryland, reducing the health burden of acute and commonly co-occurring chronic conditions. The ICTR Hub will also elevate team science by integrating opportunities, resources, and infrastructure for cross-system and cross-university research; create trust and sustained partnerships within the community, including a strong patient-centered research focus; build new capacity for clinical research informatics, including new electronic medical record capabilities that support remote clinical trial work; provide integrated, comprehensive services; and develop new knowledge that benefits Maryland and the National CTSA consortium. In the next grant cycle, we will build on this successful foundation with the following Specific Aims.

Public health relevance
By identifying and overcoming barriers in the translational pathway, increasing scientific collaboration, providing consultative services, clinical research infrastructure, and technology cores that bridge the gap between the laboratory and the clinic, the ICTR helps to speed the pace of scientific discovery, bringing effective therapies to the public, and ultimately improving the health of Americans. Our large ICTR includes the universities and health system in Maryland that have the most research activity. We expect to leverage these organizations to create high impact research that can move Maryland to better health outcomes and health equity.